Biology of Infectious Diseases Training Program

ABSTRACT
This proposal requests funding for years 21-25 of the UCSF Biology of Infectious Diseases Training Program
to train physician-scientists in infectious diseases translational research, both clinical and laboratory-based, for
research-intensive or research-related careers in academia, industry, and the public health sector. Funding is
requested for four postdoctoral trainees per year, MDs or MDs with dual degrees, recruited from the UCSF
Adult Infectious Diseases and the Pediatrics Infectious Diseases Fellowship Programs. This training program
is designed to provide flexible but rigorous protected research training in relevant laboratory-based,
translational, and clinical research in the areas of epidemiology, public health, global health, HIV/AIDS,
genomics, antimicrobial resistance, microbial pathogenesis and host response, and immunology. The 31
participating faculty are drawn from 7 departments from the UCSF School of Medicine (Medicine, Biochemistry
and Biophysics, Epidemiology and Biostatistics, Microbiology and Immunology, Pediatrics, Dermatology) and
the University of California, Berkeley School of Public Health Division of Infectious Diseases and Vaccinology.
Participating faculty have been selected on the basis of research area and expertise, funding, productivity, and
proven success in training and mentoring post-doctoral fellows. Each fellow will undertake an in-depth
research project supervised by one or more of the participating faculty. Emphasis is placed on personalized
training and instruction. The educational program provides for special courses, small group conferences,
research conferences and seminars, coursework in immunology, microbial pathogenesis, biostatistics,
epidemiology, study design, scientific writing, and responsible conduct of research. The quality and
effectiveness of the program is measured by the success of trainees in completion of fellowship training, the
number and quality of publications in peer-reviewed journals and research presentations, obtaining research
funding (e.g., independent research awards, K-awards or equivalent career-development awards, R01-level or
equivalent awards), and attainment of a research-oriented career as medical school faculty, in industry, or in
the public health sector. The career development component continues to be strengthened through a process
of regular and rigorous review and feedback of progress and performance to assure that trainees achieve their
career goals. Of the 52 fellows supported by the training program since 2000, 45 (87%) are still in health-
related careers, underscoring the extraordinary success of our training program. Funding is requested to
continue this highly successful program.

Public health relevance
PROJECT NARRATIVE Infectious diseases are the third most common cause of death in the United States, despite availability of antibiotics, vaccines, and high standards of public health, and the leading cause of death worldwide. Our program supports training of infectious diseases specialists in laboratory and clinical sciences to prepare them for careers in academia, industry, and the public health sector in the treatment, control, and prevention of infectious diseases.